UCSF-Stanford Pediatric Device Consortium

PROJECT SUMMARY
There is a critical clinical and commercial unmet need for novel pediatric devices that are designed specifically
for the unique needs of children. The UCSF-Stanford Pediatric Device Consortium (PDC) has been a key player
in this space since its inception in 2009, with a successful history in supporting over 250 pediatric device
innovations in many clinical specialties and in all device classes on their path to commercialization and patient
access. In the previous 5-year grant cycle, the UCSF-Stanford PDC supported 128 projects in research,
development, and engineering, 67 projects in bench and animal testing, 21 projects in intellectual property, 55
projects in regulation, 71 projects in business and commercialization, and 30 projects in payment and
reimbursement. This has led to over $100M in collective follow-on funding, 9 commercially available products,
and over 20,000 children positively impacted by these technologies. The UCSF-Stanford PDC is also proud to
be the first PDC to effectively use real-world clinical data and real-world evidence for successful regulatory
clearance of a device and label expansion for pediatric use.
UCSF-Stanford PDC combines the outstanding resources and unique innovation ecosystems available in two
world-class universities and two leading children’s hospitals with the unsurpassed entrepreneurial network in the
heart of the Bay Area, to equip pediatric innovators at all stages of development to translate their innovations
into high-value, commercially viable, and equitable products that are accessible to all populations. The PDC is
now further expanding its scope and impact through 1) a partnership with world-class device incubator Fogarty
Innovation, 2) the diversification of leadership with actionable plans to promote diversity, equity and inclusion
(DEI) in device development, and 3) the expansion of real-world evidence (RWE) consulting and education
through a collaborative PDC Service Center as well as a new partnership with a leading RWE firm, Aetion.
Two seasoned device innovators, Hanmin Lee, MD (Pediatric Surgeon and Surgeon in Chief at UCSF Benioff
Children’s Hospitals) and James Wall, MD (Pediatric Surgeon and Biodesign Lead, Stanford University) will lead
the PDC team consisting of device experts with clinical, technical, regulatory, and other relevant expertise. They
will be supported by senior medtech industry professionals, multidisciplinary advisory committees, and multiple
institutional stakeholders (UCSF-Stanford Center of Excellence in Regulatory Science and Innovation, clinical
trials offices, and DEI Council),to catalyze promising pediatric device innovations to viable commercial products.
Through committed leadership, collective efforts, great resources, and the unique expertise gained from previous
grant cycles, the UCSF-Stanford PDC will be able to achieve the objectives detailed in the proposal to accelerate
many high-impact, value-based pediatric device solutions to commercialization and patient impact. The UCSF-
Stanford PDC will continue to play a leadership role, along with other PDCs, in creating a national network and
ecosystem to foster pediatric device innovations.

Public health relevance
Project Narrative A great need currently exists for medical devices specifically designed and labeled for children due to several unique challenges in this area. The UCSF-Stanford Pediatric Device Consortium (PDC) will leverage the team’s established device innovation talent and resources developed over the last decade, additional resources from participating institutions, and an unsurpassed entrepreneurial network in the region to provide total product life cycle support to pediatric device innovators. During this process, the PDC will maintain a commitment to diversity, equity, and inclusion to facilitate the translation of device innovations into high-value, commercially viable products which truly serve all pediatric populations.